UM Clinical Neuroscientist Training Program

Abstract
There is a marked gap between our ability to treat neurologic diseases and our rapidly increasing
understanding of normal nervous system function, disease pathogenesis, and disease pathophysiology.
Improving treatment of neurologic diseases requires considerably improved integration of burgeoning basic
neuroscience with clinical practice across the translational spectrum from basic discovery through translational
and clinical research. An obstacle to improved integration of disease-oriented neuroscience research activities
and more efficient translation is a deficit of appropriately trained clinician-neuroscientists. American medical
schools graduate significant numbers of physicians with substantial research experience, including MD/PhDs
and individuals with significant experience with and formal training in clinical research. The traditional clinical
training structure, however, impedes the ability of these talented and well-trained individuals to efficiently
initiate productive, independent research careers. We propose continuation of a residency-fellowship based
training program integrating residency-fellowship based clinical training with mentored research training to
move talented and experienced trainees in Neurology, Pediatric Neurology, Neurosurgery, and
Neuropathology to the initial stage of an independent career. The University of Michigan Clinical
Neuroscientist Training Program (UMCNTP) prepares talented clinician-neuroscientists for independent
research careers across the full spectrum of disease-oriented neuroscience research. The UMCNTP is an
integrated residency-fellowship program preparing talented early-career clinician-neuroscientists for
successful applications for initial independent career support. The UMCNTP melds productive mentored
research experience under the guidance of experienced senior investigators with focused didactic and handson
career training to prepare UMCNTP trainees for successful career development applications such as K08, K23,
VA CDA, or equivalents. Our residency programs matriculate talented individuals without significant prior
research experience. For those individuals, the UMCNTP offers an integrated residency-fellowship-PhD
training program in Neuroscience and other relevant disciplines. The UMCNTP features a strong roster of
mentors in the Depts. of Neurology, Neurosurgery, and Pathology, and the Division of Pediatric Neurology,
access to other suitable mentors in the large University of Michigan Neuroscience community, a training
program based on highly successful prior experiences with training clinician-neuroscientists, and utilizes
excellent career development resources available at the University of Michigan.

Public health relevance
Narrative Relevance to Public Health Physician-neuroscientists bring indispensable skills to disease-oriented research and facilitate the integration of research and clinical practice. This program will improve the supply of physician-neuroscientists starting independent research careers.